Administrative Core

PROJECT SUMMARY (ADMINISTRATIVE CORE)
The work of the Administrative Core (AC) is crucial to the success of the New York University (NYU)
Collaborative Center in Children’s Environmental Health Research and Translation (CEHRT). It will lead and
organize four thematic Research Working Groups that will fuel work of the Translation and Development Cores
in collaboration with other CEHRTs and the broader CEH research community. The Administrative Core will
also provide centralized management and coordination of all administrative, dissemination, and financial
aspects of the NYU CEHRT. The AC will handle all interactions between NYU Grossman School of Medicine’s
(NYUGSOM’s) Sponsored Programs Administration, its Institutional Review Board, and other research support
institutions at NYU. It will facilitate communication among the core leaders, institutional resources, the broader
CEH community and NIEHS program staff. In addition, the AC will support multidirectional communication
among the NYU CEHRT members and external stakeholders at local, national and international levels to
ensure that translation efforts promote meaningful and consistent exchange and reflect stakeholder
priorities and concerns. The AC will also manage an Internal Advisory Committee and an Independent
Advisory Committee to assist in evaluating the merit, value, and ongoing relevance and importance of
individual organizational elements to accomplish the overall goals of the NYU CEHRT. The Administrative
Core will also centralize evaluation of Center as well as individual pilot projects across the Development and
Translation Cores. It will measure the impact of NYU CEHRT-sponsored pilot project awards on the following
domains: a) influence on the field of children’s environmental health; b) development and sustainability of
transdisciplinary research collaborations; c) investigator development competencies in translational
environmental health research and population science methods; d) productivity as measured in peer-reviewed
and high impact publications and research funding; and e) reach and utility of dissemination products. The
Administrative Core will prepare translation stories and tabulate the aggregate NYU CEHRT effort to support
Independent Advisory Board and Program Office evaluation.